Mentoring Clinical Investigators in Psychedelic-Assisted Therapy for HIV (Mentor-PATH)

Project Summary/Abstract
Research on psychedelics, substance use (SU), and mental health (MH) has shown promising results in the
treatment of depression, anxiety, post-traumatic stress disorder, alcohol use disorder, and smoking cessation.
Psychedelics can promote the development of new neural pathways, which may lead to improved health
outcomes. Psychedelic-assisted therapy (PAT) involves the professionally supervised use of psychedelics as
part of a psychotherapy program and offers a paradigm shift for more effective and safer options for SU and
MH treatment. PAT could improve the lives of people with HIV (PWH) who experience SU or MH challenges at
rates higher than the general population. These SU and MH challenges are strongly associated with lower
medication adherence, reduced virologic suppression, disease progression, and high mortality among PWH.
Treatment of SU and MH concerns can reverse adverse health effects, lead to improved clinical outcomes, and
prevent onward HIV transmission. Therefore, parallel to the HIV treatment cascade, there is an urgency to
address and achieve global treatment goals for SU and MH challenges. However, the low representation of
minority groups among health researchers undermines the ability of public health interventions to address
these health disparities. There is an urgent need for more diversity in the HIV research community, and
building a pipeline of researchers from diverse backgrounds is critical to advancing science. In this K24, Dr.
Parya Saberi proposes a plan to (1) provide mentorship to early career trainees from diverse backgrounds; (2)
provide opportunities to develop her knowledge and skills in research related to SU, MH, PAT, and
implementation science; and (3) provide preliminary data to inform subsequent patient-oriented research
proposals by her and her mentees to address equity in SU or MH treatment and PAT among PWH. Therefore,
Dr. Saberi’s mentoring goals include increasing the number of her mentees, enhancing her mentoring
competencies, and providing a training program for mentees from diverse backgrounds to launch and support
their careers. Mentees will leverage the infrastructure and resources of Dr. Saberi’s ongoing research and her
collaborations with multidisciplinary researchers in the areas of HIV, SU, MH, PAT, and implementation
science. The research aims of the proposed K24 are: (1) to assess the interests, concerns, motivators, and
deterrents of using PAT among PWH experiencing moderate to severe SU or MH challenges and (2) to
examine priorities for the research agenda and future clinical implementation of PAT among PWH experiencing
SU or MH challenges. Therefore, funding from this K24 will allow Dr. Saberi to grow a structured program of
training for researchers from diverse backgrounds and to conduct research that addresses the need for
effective SU and MH interventions, enhanced scientific rigor in PAT research, and increased research to
improve health equity for SU and MH treatment among PWH.

Public health relevance
Project Narrative The mentoring aims of Dr. Parya Saberi’s K24 application are to provide effective mentorship to trainees from diverse backgrounds by enhancing her mentoring competencies, increasing the number of her mentees, and providing a training program for mentees to launch and support their careers. The overarching research aims of the proposed K24 are to provide new insights into the potential of psychedelic-assisted therapy as a treatment for substance use and mental health challenges among people with HIV and to identify priorities for the research agenda and future clinical implementation of psychedelic-assisted therapy for people with HIV.